MK-212 ON SERUM CORTISOL, PROLACTIN AND GROWTH HORMONE

The status of specific serotonin receptor subtypes in psychiatric disorders may be longitudinally assessed by determining the hormone response following administration of MK-212 to psychiatric patients. Functional antagonism of the MK-212-indirect hormone responses may better determine the mechanism of this agent and the function of serotonin receptor mechanisms in mental disease.